Development of AI/ML-ready shared repository for parametric multiphysics modeling datasets: standardization for predictive modeling of selective brain cooling after traumatic injury

ABSTRACT
By rapidly and selectively cooling injured brain tissue, we can dramatically mitigate the long-term effect of trauma
to the head. As part of the NIH-funded R21, we are developing a stylet that could be easily inserted in commonly
used extra ventricular catheters to add cooling to intracranial pressure control. As we are developing the device,
we also realize the need for using AI/ML algorithm for optimizing design of the device and treatment planning.
Unfortunately all the commercially available software that run multiphisic numerical simulation produce data that
is not ready for processing by artificial intelligence and machine learning (AI/ML) technologies. Although AI/ML
are data-driven technologies could potentially revolutionize biomedical research, most research data is not
readily useable by AI/ML applications. In particular, there is the widespread and urgent need to make AI-ML
ready the large parametric datasets generated by multiphysics numerical simulations.
This supplemental project aim to address that issue and create a framework template for other clinical/basic
research groups to make AI/ML ready data from complex predictive multiphysics modeling to enhance
significantly their optimization and prediction capabilities. These simulations can rapidly and accurately predict
the behavior of complex biomedical devices in phantom, preclinical and clinical settings. Parametric predictive
multiphysics modeling (PPMM) allows researchers/clinicians/patients to study the effects of potential variations
in manufacturing, treatment parameters, anatomical features and physiological responses on treatment
procedures. These sensitivity studies produce significantly large datasets that could be rapidly process by AI/ML
algorithms to optimize clinical procedures. As part of a recently awarded R21 grant, we are developing a new
device that can rapidly and selectively cool the cerebral tissue of traumatic brain injury patients. Rapid selective
brain cooling could dramatically improve patient outcomes by minimizing secondary injuries.
PPMM using commercially-available software (Comsol, Ansys, Matlab, CST and others) is used both at the
design stage and during the treatment planning phase. However, the significant amount of PPMM data is not
ready for AI/ML processing since each 4D database lack of reference to the original set of parameter (i.e. tissue
properties, perfusion rate, type and location of injury…). We thus plan, within the proposed supplemental
research, to address these specific aims: 1) Develop and disseminate an AI/ML-Ready PPMM dataset 2)
Demonstrate the Usability of the AI/ML-Ready PPMM dataset in an AI/ML application (optimization of treatment
planning) 3) Demonstrate the usability of the AI/ML-ready PPMM dataset with student engagement activities.
Although the research will be focused on brain cooling PPMM, the approach will be easily expandable to other
PPMM such as cancer thermal ablation, brain temperature monitoring of hypothermic cardiac surgeries and early
detection of aggressive breast cancer. The proposed research will pave the way to the full potential of AI/ML
technologies in tandem with multiphysics simulations for the benefit of traumatic brain injury patients.

Public health relevance
PUBLIC HEALTH AND RELEVANCE STATEMENT We propose to create an AI/ML-ready database from multiphysics numerical simulations that can dramatically accelerate the optimization and predictive capabilities during medical device development and treatment planning. Although we will customize the database for brain cooling application, the framework we are developing is a template for the many basic/clinical applications that rely on parametric multiphysics modeling to optimally design medical device or treat patients. The novel, affordable, effective approach has the potential to unleash the full predictive capabilities of AI/ML processes that are trained on multiphysics parametric databases, ultimately improving the quality of life of patients and lower the cost of healthcare even in low-resource settings.